Administrative Supplements to Expand NCI-supported Community Outreach Capacity through Community Health Educators (CHE) of the National Outreach Network (NON)

PROJECT SUMMARY The Hollings Cancer Center (HCC) at the Medical University of South Carolina (MUSC) seeks renewal of its National Cancer Institute (NCI) National Outreach Network (NON CHE) funding for an additional two years. As in our currently funded NON CHE grant, the Specific Aims are: Specific Aim 1. Expand, refine and evaluate the MOVENUP evidence-based, small-group, community Train the Trainer cancer educational sessions to focus on HPV vaccination uptake in the rural I-95 Corridor of SC, in partnership with the African Methodist Episcopal Church of SC. Specific Aim 2. Conduct cancer clinical trial- and biospecimen collection-focused educational sessions to recruit participants to the MUSC-HCC’s NCORP studies. (Please note that the wording of Specific Aim 2 was changed slightly from: “Conduct cancer clinical trial- and biospecimen collection-focused educational sessions with the patients served at the MUSC-HCC’s NCORP sites in SC.”) Specific Aim 3. Conduct an Annual Community Compass in the SC Upstate Region. During the current funding period (April 1, 2019 – March 31, 2021), our NON CHE program reached 342,700 SC residents through radio/TV/public media announcements related to HPV, clinical trials, and COVID-19 information. We delivered MOVENUP sessions to 298 participants who completed 278 pre -test/post-test surveys (92% completion rate). All 278 completed surveys were sent to the NCI for analysis. Additionally, we referred 77 participants to the NCI’s Tomosynthesis Mammographic Imaging Screening Trial (TMIST) taking place at the NCI Community Oncology Research Program (NCORP) Minority/Underserved site at the MUSC -HCC. The NON CHE renewal grant will pave the way to future extramural funding to support the community engagement strategies described herein. The MUSC-HCC COE, led by Dr. Ford, is strongly committed to continuing to leverage its funding to support and sustain the ongoing activities of the CHE.

Public health relevance
NARRATIVE The SC cancer mortality rate is 27% higher for African American/Black (AA) men than for White men, and 14% higher for AA women than for White women. The NON CHE program, a cancer control initiative, will disseminate culturally appropriate, evidence-based cancer health information messages, with the goals of increasing HPV vaccination rates and increasing rates of participation in cancer clinical trials and biomedical research.